PROJECT 1: Modulating blood cell heterogeneity to reduce cardiovascular inflammation

ABSTRACT
This proposal focuses on how the atherogenic state leads to the selective outgrowth of cell
clones that are epigenetically restricted in their behaviors. It is based on prior work
demonstrating that stem and progenitor hematopoietic cells are not highly plastic responding in
different ways to different challenges. Rather, they have functional attributes scripted in their
epigenome and subsets of clones selectively respond to challenges. Cells are selected by
heritable functions; they are not blank slates in which a functional phenotype is induced. In the
context of cardiovascular disease (CVD), this means that the atherogenic state selects for
specific clones that then propagate atherogenesis in a self-reinforcing manner. We hypothesize
that this occurs not just among hematopoietic cells but also in the bone marrow stromal cell
subsets we have defined and that stroma and blood co-conspire to accelerate CVD. In this
proposal, we test clonal outgrowth in both types of cells under different types of atherogenic
states and in the context of specific neural modifiers of atherogenesis. We then test whether
modifying epigenetic features of cells can modulate CVD. Our goal is to define means of
interrupting the pathogenic systems biology of CVD.